The Influence of Fluid Administration on the Effects of Tumor Necrosis Factor So

Despite encouraging results in preclinical studies, clinical experience with anti-inflammatory in patients with sepsis have been disappointing to date. Tumor necrosis factor soluble receptor (TNFsr) is one agent. In early preclinical work utilizing endotoxin or gram-negative bacteria infusion challenges, TNFsr was protective and improved survival. This protection appeared to be related to improvements in cardiovascular function with TNFsr. However, in clinical sepsis trials this agent was not beneficial and in some cases appeared to have harmful effects. These finding suggest that factors not identified in preclinical studies may have altered the effects of TNFsr in clinical studies. One such factor may be the presence or absence of other supportive therapies. In clinical studies, subjects also have cardiovascular support with fluid administration. The presence of such support in clinical studies may have negated the beneficial effects of TNFsr on cardiovascular function and possibly accentuated adverse effects it may have had on host defense. In the present study, using a multifactorial design, we are testing the effects of fluid administration on TNFsr with both intravascular and extravascular infection in a rat model of sepsis.